COMPARATIVE STUDY OF EFFECT &EQUIVALENCE OF SIROLIMUS

To demonstrate equivalent efficacy of Sirolimus (SRL) oral liquid versus SRL tablets administered concomitantly with cyclorsporine (CsA) and corticosteroids in de novo renal allograft recipients. Efficacy will be assessed by a composite endpoint of the incidence of first 3 months after transplantion.